Phytochromes: Structural Perspectives on Photoactivation and Signaling

PROJECT SUMMARY
Almost all cellular organisms employ an array of photoreceptors to detect their light environment. Arguably the most
influential are the phytochromes (Phys), a diverse group essential for plant development and the behavior of many bacterial,
fungal, and algal species. By reversible photointerconversion of their bilin (or open-chain tetrapyrrole) chromophores
between red light-absorbing Pr and far-red light-absorbing Pfr states, Phys act as photoswitches in various signaling
cascades responsive to light intensity, duration, direction, and spectral quality. Moreover, through the thermal reversion of
Pfr back to Pr, some Phys sense temperature through enthalpic effects on this reaction, and perceive photoperiod through
the nighttime depletion of Pfr. The cumulative effects of this Pr/Pfr interconversion impact numerous physiological
processes important to agriculture and the biology of harmful plant and human pathogens. In addition, their unique
photochemistries provide invaluable optogenetic tools, including novel fluorophores for tissue imaging, and engineered
photoswitches for regulating cellular events with remarkable temporal and spatial precision.
Recently, we made great strides in understanding how Phys signal, with emerging structures suggesting that microbial and
plant Phys use two distinct output modalities. Both start with light-triggered isomerization of the bilin, which drives a -
stranded to -helical rearrangement of a hairpin loop that links the signature PHY and GAF domains. While photoactivated
microbial Phys then connect torsional strain generated within the dimer to regulate an appended output domain (typically
with histidine kinase activity), plant Phys have rearranged their domain organization to create a photosensitive dimeric
platform that likely enables reversible binding and eventual degradation of the family of PIF transcriptional repressors.
While current models helped illuminate gross changes required for endstate conversion, the intermediates of photoexcitation
and ensuing structural changes necessary for creating a signaling-competent Pfr state remain uncertain.
The objectives of this proposal are to complete these pictures through continued X-ray crystallographic and cryo-electron
microscopic approaches followed by informed biochemical analyses of representatives in their inactive and active states.
Specific aims are to: (1) exploit time-resolved serial X-ray crystallography to structurally define the intermediates generated
by Phys after photon absorption; (2) generate more comprehensive structures of bacterial Phys, including models of full-
length dimeric photoreceptors with their signal output modules; (3) develop a model for how plant Phys signal through
structural studies on Pfr; (4) apply steady-state and time-resolved protein surface mapping to support the Phy
photoconversion pathway(s) seen structurally; (5) develop models of Phys interacting with their downstream effectors, and
(6) appreciate how diversity among plant Phy enables thermal/time perception by specific isoforms.
Taken together, this project will provide an essential framework to better appreciate the structure, allosteric mechanisms,
and evolution of the Phy superfamily. Understanding how microorganisms and plants sense light, temperature, and time
would then have important ramifications for improving the agricultural performance of crop plants, understanding microbial
ecosystems, controlling medically-relevant pathogens, and furthering the application of Phys as optogenetic reagents.

Public health relevance
PROJECT NARRATIVE Part of the NIH mission is to seek fundamental knowledge about the nature and behavior of living systems, and to apply this knowledge to enhance human health and lengthen life. Our proposed research is relevant to this mission because it seeks to understand how plants and microorganisms, some of which are medically-relevant pathogens, use the phytochrome (Phy) family of photoreceptors to gather information about their light environment and adjust their growth and development accordingly. In addition, given the widespread biotechnological use of Phy variants both as novel fluorophores and as engineered photoswitches, a further understanding of Phy structure and photochemistry should accelerate the development of advanced optogenetic tools for tissue imaging and the precise spatial and temporal control of cellular events.